UM Calabresi Clinical Oncology Research Career Development Award

PROJECT SUMMARY/ABSTRACT
The University of Miami (UM) Sylvester Comprehensive Cancer Center (SCCC) K12 Calabresi Clinical Oncology
Research Career Development program is designed to formalize a structured path to independent translational
science that, at the core, is a strong foundation for clinical trial development and implementation that is intended
to culminate in impactful changes in oncology patient management. Over the initial period of the grant, the SCCC
achieved NCI designation and has committed significant resources to building and sustaining robust academic
physician faculty recruitment and mentorship programs that are tied to strategic enhancement of the candidate
pool for the K12 physician-scientist program. Candidate physician-scientists are recruited from all cancer related
specialties. Department and Division chiefs at UM have promoted the program to incoming faculty completing
their fellowships and residencies, and existing junior faculty within 5 years of completion of fellowship training.
Scholars include those who recently completed postgraduate training in a subspecialty oncology program:
pediatric, urologic, radiation, surgical, hematology (liquid tumors), medical (solid tumors), cell transplant, head
and neck, ophthalmologic, gynecologic oncology. Of the 10 scholars who have entered, 4 are from hematology,
2 are from medical oncology, and 1 each are from surgical oncology, cell transplantation, urology, and radiation
oncology. The PI of the K12 program is a radiation oncologist physician-scientist who has been the PI of phase
I, II, and III trials and mentored numerous students, trainees, and faculty in translational research and clinical
trial advancement. He organizes the K12 Design and Management of Clinical Trials course (CTC), which serves
as a cornerstone of the curriculum. The K12 CTC has evolved into an inter-institutional course designed to
enhance exposure of and recruitment into the K12 Program. There are two Associate Directors including (i) a
medical oncologist (Jaime Merchan, MD) who leads the SCCC Phase I Program (the only such program in South
Florida) and who oversees the homework portion of the CTC, wherein scholars and other invited faculty and
fellows have their clinical trial concepts developed and critiqued; and (ii) a population scientist (Erin Kobetz, PhD,
MPH) who is Associate Director of Population Sciences and Cancer Disparity in SCCC, as well as Vice Provost
for Research and Scholarship for UM. Dr. Kobetz oversees the link between the scholars and community/patient
advocates. The Internal and External Advisory, Executive, and Curriculum Committees provide feedback and
are attuned to the need to have a diverse group of applicants to choose from. Based on feedback from the
committees and scholars, revisions are being made to the core curriculum and Master of Science program run
in collaboration with the UM Clinical and Translational Science Institute (CTSI). The collaboration with the CTSI
KL2 program at UM has been formalized with a joint SCCC K12 and CTSI KL2 application process and
standardized review criteria. As the CTSI KL2 transitions to a K12, we are working together through cross-
committee participation to optimize these complementary and independent programs.

Public health relevance
PROJECT NARRATIVE This is a renewal application requesting continued funding for the Sylvester Comprehensive Cancer Center K12 Calabresi physician-scientist training program. The first group of graduating scholars are representative of successful recruitment and support, as all three have obtained extramural funding. The curriculum is evolving to better meet the needs of the scholars and for novel outreach to grow the pipeline of physician-scientist investigators from diverse backgrounds.